PATHOGENETIC FACTORS IN THE HYPERTENSION OF POLYCYSTIC DISEASE

Normal controls, essential hypertensives, and normo and hypertensive adpkd subjects will have forearm venous volumes measured on high sodium intake during exercise, phentolamine, enalapril, vasopressin antagonist.